Bioinspired mechanogating biosensors for real-time biodetection

Project Summary
Electronic biosensors have been playing increasingly important roles in medical diagnostics. Early
detections of various biomarkers are desired to provide timely diagnosis for the prevention and treatment of
diseases. However, current electronic biosensors are limited in biodetection, often attributed to nonspecific
interferences from a complicated ionic environment in bodily solutions. Specifically, charge screening has
prevented field-effect biosensors from real-time biodetection in physiological environment. We intend to bring
in and validate a new biosensor concept, which can be free of nonspecific charge interference and provide
generic solution to the specific biodetection. We also intend to apply the biosensor in the early detection of tick-
borne diseases, which have imposed serious threat to public health but lacked means in early detection for
timely treatment. Inspired by the mechanotransduction in biological organelles, we will employ a
`mechanogating' sensing mechanism that is orthogonal and hence resilient to charge interference. Specifically,
we propose to design a biosensor based on a suspended nanotransistor exposed to analyte flow; the binding
biomolecules are expected to increase the effective cross-sectional area of the nanotransistor and hence the
drag force by the fluid flow; the induced strain will lead to a conductance change through the piezoresistance
effect.
To realize the goals, in Aim 1 we will assembly and integrate highly suspended nanotransistors as the
biosensors specifically designed for the proposed sensing mechanism. In Aim 2, we will evaluate and verify the
biosensor function and performance in high ionic strength mimicking the physiological environment. In Aim 3,
we will implement the biosensor for the selective detection of pathogens of tick-borne diseases. If successful,
the biosensor will provide a practical solution for improved/timely treatment in tick-borne diseases. The
research is expected to create a new class of biosensors, which will transcend the inability of field-effect
biosensors and realize generic biodetection in physiological environment, leading to advanced biomedical
devices for versatile point-of-care diagnostics.

Public health relevance
Project Narrative Electronic biosensors are important for health diagnostics, disease prevention and treatment, although nonspecific charge interferences have prevented conventional biosensors from real-time detection in physiological environment. The proposed research intends to bring in and validate a new biosensor concept, which can be free of nonspecific interference and provide generic solution to the specific biodetection in physiological environment, potentially leading to advanced biomedical devices for point-of-care diagnostics. The sensor concept will be concreted by implementing it in the early detection of tick-borne diseases, which currently have imposed serious threat to public health but lacked timely diagnostics.